Specification And Patterning of the Lymphatic System

Our identification and characterization of a lymphatic vascular system in the zebrafish made it possible to bring the powerful genetic, experimental embryologic, and imaging tools available in this model organism to bear on the question of how lymphatic vessels form and what regulates their growth and assembly. Understanding how to regulate and control lymphatic vessel formation is a topic of considerable clinical interest given recent evidence suggesting that lymphatics are the major route for tumor metastasis in many if not most cancers. The long-term goal of this project is to expand on our preliminary findings in order to gain a more detailed understanding of how lymphatic vessels assemble in the fish, and then use this powerful model to study how lymphangiogenesis is regulated in vivo.

The lymphatic system has become a subject of great interest in recent years because of its important role in normal and pathological processes, but progress in understanding the origins and early development of this system has been hampered by difficulties in observing lymphatic cells in vivo and performing defined genetic and experimental manipulation of the lymphatic system in currently available model organisms. We demonstrated that the zebrafish possesses a lymphatic system that shares many of the morphological, molecular, and functional characteristics of the lymphatic vessels found in other vertebrates (including humans), providing a superb model for imaging and studying lymphatic development. We have used the genetic and experimental advantages of the fish to examine the origins of lymphatic progenitors and uncover mechanisms directing the assembly and patterning of lymphatic vascular networks.

We are currently pursuing further study of the formation of the lymphatic system through a number of ongoing projects:

1. We are performing high-resolution imaging of transgenic lines we generated that permit direct, specific visualization of the developing lymphatic vasculature to further characterize how the lymphatic vascular system grows and assembles during development.

2. We are studying mutants with lymphatic vessel phenotypes to uncover the roles of novel genes important for lymphatic development.

3. We are analyzing global and tissue-specific patterns of lymphatic gene expression using newly developed transgenic tools that facilitate lymphatic-specific profiling.

4. We are studying an unusual brain perivascular cell population derived from venous-lymphatic endothelium that we have identified.

5. We are studying the formation of novel lymphatic networks in the zebrafish meninges and in the axillary lymphoid organ (ALO), a superficial lymph-node like structure we recently discovered in the zebrafish, and we are examining immune cell-lymphatic cross-talk in these tissues.

6. We are characterizing novel Lymphatic Capillary Mural Cells (LCMCs) that we recently discovered in the zebrafish, the first time that these important supporting cells have been shown to be associated with lympahtic capillaries.

The results of our studies, combining the genetic and experimental tools available in the zebrafish with the ability to perform high-resolution microscopic imaging of developing vascular structures in living animals, will continue to lead to important new insights into the origins and growth of the lymphatic system and reveal the molecular mechanisms critical for lymphatic development and lymphatic pathologies.